SOTALOL HYDROCHLORIDE FOR CONTROL OF ARRHYTHMIAS IN CHILDREN AND ADOLESCENTS

In this project, the safety and efficacy of oral sotalol in children with significant symptomatic supraventricular or ventricular arrhythmias are evaluated.